Characterizing ART-free NK cell-mediated control of HIV infection in people living with HIV

PROJECT SUMMARY
People living with HIV (PLWH) can be treated effectively with antiretroviral therapy (ART) but for most, as soon
as ART is stopped, HIV quickly rebounds within weeks. However, in rare individuals, called post-treatment
controllers (PTCs), HIV is controlled by immune-mediated mechanisms and viral rebound is suppressed. How
this occurs remains poorly understood. One type of immune cell in PTCs that has been implicated in viral control
during ART interruption is Natural Killer (NK) cells. These cells can rapidly respond to and kill infected cells as
part of a classical innate immune response, but more recently has also been suggested to be capable of
harboring “memory” against prior infection including that by HIV. This “memory” is thought to be in part mediated
through epigenetic mechanisms. The types and features of NK cells in PTCs, and whether they differ from those
in non-controllers (NCs), is not known. A better understanding of these cells is the first step towards
understanding how they can control HIV and be harnessed for therapy. The objective of this proposal is to
deeply characterize the features and effector functions of NK cells in PTCs and non-controllers (NCs), and to
identify biomarkers on NK cells prior to analytical treatment interruption (ATI) that predict HIV remission. We
hypothesize that NK cells, including memory NK cell subsets, help to control HIV after ART is removed in PTCs.
We will use longitudinal samples from clinically-matched PTCs and NCs from the CHAMP study, sampled ATI,
and at early (within 12 weeks) and late (after 24 weeks) timepoints after ATI. In Aim 1, we will use mass cytometry
(CyTOF) to determine the phenotypes and effector functions of NK cell subsets from PTCs and NCs before and
after ATI. In Aim 2, we will use multiplexed single-cell RNAseq and single-cell ATACseq to identify transcriptional
and epigenetic signatures of memory and non-memory NK cells from PTCs vs. NCs after treatment interruption.
Understanding immune responses capable of mediating HIV remission provides an avenue for development of
novel therapeutics to cure HIV. Equally essential are non-invasive biomarker(s) that predict HIV remission for
safer treatment interruption trials. This proposal addresses both these aspects focusing specifically on NK cells,
powerful immune effectors that are much understudied with regards to their potential to mediate HIV remission.

Public health relevance
PROJECT NARRATIVE In rare individuals called post-treatment controllers (PTCs), interruption of antiretroviral therapy (ART) does not result in HIV rebound because the virus is somehow controlled by the immune system. One type of immune cell that may help mediate control HIV in PTCs are Natural Killer (NK) cells, which are potent antiviral effectors and classically players of the innate immune system, but have also been shown to have “memory” of viral encounter. The objective of this proposal is to characterize the features and effector functions of NK cells, including those with “memory”, from PTCs as compared to those from clinically-matched non-controllers, in order to better understand the potential mechanisms by which NK cells may contribute to HIV control ART-free HIV control.